Defining the complex genetic basis of Plasmodium falciparum resistance to artemisinin and quinine and identifying resistance-refractory therapeutics

PROJECT SUMMARY
Malaria morbidity and mortality rates have rebounded in recent years and threaten to further increase,
as a predicted consequence of the recent emergence and spread in east Africa of Plasmodium
falciparum (Pf) strains resistant to first-line artemisinin (ART) derivatives. ART resistance is likely to
increase selective pressure on the partner drugs used in ART-based combination therapy, as evidenced
in Uganda where parasites are also displaying decreased susceptibility to the first-line partner drug,
lumefantrine. Recent data suggest that the dissemination of ART-resistant strains across sub-Saharan
Africa will require mutations in the primary determinant k13 as well as additional determinants that can
augment resistance and overcome fitness costs associated with mutant k13. To identify these
determinants, we genetically crossed a drug-sensitive African parasite with an ART-resistant parasite
from Southeast Asia, where resistance arose a decade earlier. By comparing the genome sequences
and ART susceptibility profiles of recombinant progeny, we associated ART resistance with mutant k13
and two additional, physically unlinked loci. In Aim 1, we propose to test the role of the prioritized
candidates mrp1 and arps10, by CRISPR/Cas9 editing their mutations into the ART-resistant parent
and several African culture-adapted strains. We will then assess their ability to mitigate mutant k13’s
fitness costs, thus enabling ART-resistant parasites to successfully compete with drug-sensitive strains
and disseminate throughout African parasite populations. We will also assess the contribution of other
genes implicated from in vitro or small animal model studies. In Aim 2, we will define the multigenic
basis of Pf resistance to quinine, a former first-line drug that represents a viable alternative to
intravenous artesunate for the management of severe malaria in regions where ART resistance
becomes prevalent. Candidate physically unlinked genes, including dmt1, a putative transporter related
to pfcrt, as well as ftsh1 and samc, have been identified from a second genetic cross involving an Asian
quinine-resistant parasite and a sensitive African strain. In Aim 3, we will leverage preliminary data to
explore Pf resistance to ZY-19489 and MMV688533, two promising antimalarial candidates in clinical
trials. We will also assess the resistance risks of the registered drugs lumefantrine and pyronaridine
where the knowledge gap is acute, as well as ferroquine and INE963 that are in clinical trials. These
experiments, which take advantage of our unique panel of hyper-mutable African and Asian strains, will
identify which of these candidate therapeutics are resistance-refractory. Achieving the goals of our
project will yield important insights into the multigenic basis of ART and quinine resistance, deliver novel
molecular markers to track the dissemination of multidrug-resistant Pf malaria, and inform the
development of future therapeutics.

Public health relevance
PROJECT NARRATIVE This research addresses the critical issue of artemisinin resistance in Plasmodium falciparum parasites, which has emerged in east Africa, and which threatens antimalarial treatment and control efforts across sub-Saharan Africa. Our project leverages recent discoveries from genetic crosses to define the multigenic basis of artemisinin resistance and identify genetic markers of resistance to quinine, an alternative first-line drug for severe malaria. We will also assess the resistance risks of currently used partner drugs and identify which of the candidate therapeutics currently in clinical trials have the lowest risk of succumbing to parasite resistance.